CORE--ADMINISTRATION AND CLINICAL

The Administrative and Clinical Core will provide the organizational underpinnings of this project and serve as the primary site for all human subject recruitment and screening for the research projects. It will be responsible for collecting demographic, genetic, clinical, neuropsychological, and structural MRI (used to co-register to PET for PET image analysis) data, as well as other relevant information needed to track and process subjects. Under Dr. Small's direction, the key personnel who will staff this core have worked together for the past decade, successfully providing clinical support for numerous grants funded by the NIH (R01) and other agencies, as well as collaborating with other personnel in the proposed program project. This core will be responsible for database management and statistical consulting;hosting and maintaining the centralized database for the entire program project and making those data available for appropriate project personnel;maintaining quality control and achieving projected project milestones;and serving as the central coordinating body for the entire project.